Administrative Supplement: Randomized controlled trial of varenicline for cessation of nicotine vaping in adolescent non-smokers

PROJECT SUMMARY/ABSTRACT
The prevalence of adolescent nicotine vaping is high with over one third of high school seniors reporting that
they vape nicotine regularly. This rapid rise in popularity of electronic nicotine delivery devices (ENDS, “e-
cigarettes”, vapes) has reversed five decades of denormalizing youth tobacco use, putting adolescents at high
risk for nicotine dependence, tobacco smoking, other drug use, and direct negative health effects of vapor
exposure. While sensible regulation raising the purchasing age and eliminating sweet and mint flavors should
curb new uptake of adolescent nicotine vaping among never smokers, these policies are causing many to seek
vaping cessation treatment. No treatment trials for vaping cessation have been published to date to our
knowledge. Effective interventions are critical to aid adolescents now with addiction to vaped nicotine to quit
vaping and not start smoking. Varenicline, the most effective known smoking cessation medication, has been
well tolerated and associated with significantly higher tobacco abstinence rates and faster time to abstinence in
secondary outcomes in two recent small randomized controlled trials in adolescent smokers. In a recent series
in our group, varenicline together with text vaping cessation support has been associated with 65% (34 of 52
patients) prolonged vaping abstinence rates (at 3-9 months follow up) in non-smoking adolescents who are
dependent on vaped nicotine, while nicotine replacement therapy has been associated with approximately 21%
abstinence rates to date in this population. In the current study, we propose to test whether varenicline, the
most effective treatment known for nicotine addiction, helps nicotine dependent adolescents to quit vaping
nicotine. To do so, we will enroll 300 adolescents, aged 16 - 25, who vape, are nicotine dependent, do not
smoke, and want to quit. Adolescents will be recruited through high schools, colleges, and the community in
Greater Boston, and those eligible will be enrolled into a double-blind, placebo-controlled, parallel group,
intent-to-treat trial of varenicline up to 1 mg bid for 12 weeks added to an active behavioral control intervention
involving 12 weeks of text messaging and group behavioral support specifically designed for teen vaping
cessation. Medication adherence and trial retention, challenges in prior adolescent smoking cessation trials,
will be incentivized and supported with the innovative EMocha smartphone application for remotely directly
observed dosing and collection of daily vaping and other data. This proposal is responsive to urgent and
growing requests for vaping cessation treatment for adolescents from patients, their families, and schools.
Positive results will define an effective treatment that can be used in this rapidly moving epidemic of youth
vaping and will fundamentally change clinical practice.

Public health relevance
Project Narrative Electronic cigarettes, initially marketed as a harm reduction product for tobacco smokers, have exploded in popularity amongst adolescents, renormalizing tobacco use in youth and bringing high risk for nicotine dependence, tobacco smoking, other drug use, and direct negative health effects vapor exposure to children. Amidst growing demand for youth vaping cessation interventions where no proven treatment for adolescent vaping cessation exists, varenicline has shown promise for vaping abstinence in clinical care. The goal of this administrative supplement is to complete a project to determine whether varenicline, the most effective treatment known for addiction to smoked tobacco, is effective for nicotine vaping cessation in adolescents.